Comparative and Evolutionary Biology of Hearing

Project Summary/Abstract
In response to an emerging need for scientists who can bring innovative skills and perspectives to problems in
the hearing sciences, we continue to build upon our well established Training Program in Comparative and
Evolutionary Biology of Hearing at the University of Maryland, College Park. The 17 Core Faculty in our group
bring an extraordinarily broad range of expertise, from cellular and molecular biology to systems neuroscience,
while also demonstrating a successful track record in training students. These capabilities allow us to offer a
training program that not only emphasizes a comparative and evolutionary perspective to understanding the
auditory system, but also does so across different levels of analysis. We propose new approaches to train the
next generation of scientists to translate knowledge and methodologies across biomedical sciences, enabling
breakthroughs that cannot be achieved through work confined to a single discipline and using a single model
system. The next cycle of our training program promotes a focus on translational research, in which we will
continue to expand our trainees' appreciation of the biomedical applications of basic research to solving
problems concerned with hearing across the human life span, including prevention, diagnosis, and genetics of
hearing impairment and relevant therapeutic interventions. Core Faculty are from four departments and one
program at UMD (Biology, Psychology, Hearing and Speech Sciences, Electrical and Computer Engineering,
and Neuroscience and Cognitive Science) and one program at the University of Maryland, Baltimore (UMB:
Graduate Program in Life Sciences). Additional associated faculty from other UMD programs, NIDCD, and
other regional institutions, such as UMB and Walter Reed National Military Medical Center, work closely with
the Core Faculty and provide further research and training opportunities for pre- and post-doctoral trainees.
The Training Program requests support for five predoctoral and two postdoctoral trainees. Predoctoral trainees
are generally selected in middle to later training years, when they are primarily engaged in research. In
addition to research training, all trainees take courses in the fundamentals of hearing and research ethics,
attend seminars/courses in professional development and translational auditory science, as well as participate
in all program activities. Emphasis throughout the program is to expose trainees to the breadth of work done in
the program’s participating labs, and through this exposure, gain a better appreciation for the range of
questions being asked and interdisciplinary research methods applied today in the hearing sciences.

Public health relevance
Project Narrative The CEBH Training Program will continue to provide in-depth and interdisciplinary training in the hearing sciences that prepares individuals to advance discovery and innovation at the interface of basic science and medicine. More complete knowledge of auditory system function promises both to solve some of the most perplexing and devastating problems of human health, and to design pioneering methodologies, systems, and devices that will transform how we live.